Structure and Relations of Protein and Nucleic Acids

Summary/Abstract for requested administrative supplement to GM-15792-57.
With this administrative supplement to our current NIGMS grant (GM-15792-57) we seek funds to purchase a
much-needed replacement surface plasmon resonance (SPR) instrument that is important for our current DNA
replication studies and for other related work of our group. Substantial parts of our ongoing research efforts are
focused on achieving a detailed mechanistic understanding of the function and control of the sub-assemblies of
the DNA replication complex of bacteriophage T4 by applying spectroscopic methods that site-specifically
position fluorescent and optically active probes in the DNA framework of the replication complex at important
protein binding sites. We use these labeled constructs to monitor – both with bulk (ensemble) solution
measurements and at the single-molecule level – biologically significant local conformational changes at defined
DNA positions that have been labeled with our spectroscopic probes.
SPR is an important analytical tool for monitoring equilibrium and dynamic properties of protein-DNA complexes,
including those in which the DNA components have been labeled with optical probes. We are pursuing two
different fluorescent probe-labeling strategies for our studies on DNA and protein-DNA interactions. We use pairs
of spectrally visible iCy3 dyes placed (internally) within the DNA backbones at defined positions to study the
structure and dynamics of local DNA backbone conformations and conformational fluctuations, while pairs of
fluorescent 6-MI base analogues, which have been substituted for natural guanine DNA bases, are used to
obtain complementary information about the structure and dynamics of the bases and base-pairs at defined sites
within our model DNA replication-fork constructs. SPR measurements provide important information to support
our ensemble and single-molecule measurements of probe-labeled systems, in addition to providing important
‘control’ information about these systems in the absence of probes.
The single-channel manual SPR instrument currently available in our laboratory (and – to or knowledge – the
only SPR instrument at our university) is over 15 years old, very time consuming to run, and its major components
are now beginning to fail. Furthermore, our present instrument is so outdated that the manufacturer no longer
supports its maintenance and components, and replacement microfluidic SPR sample cell ‘cartridges’ are no
longer available commercially. We will soon exhaust our dwindling supply of these cells, which will then put our
current instrument completely ‘out of business.’ For the above reasons, we herewith request funds to purchase
a replacement multi-channel automatized SPR instrument, which will take much less time to run and will greatly
facilitate our ongoing spectroscopic experiments, as well as our other ongoing studies of protein-nucleic acid
interactions. [We note that our laboratory has considerable experience with using SPR techniques for studying
protein-nucleic acid interactions – see Greive et al., Proc. Nat. Acad. Sci., 105, 3315, (2008); Greive et al.,
Biophys. J., 101, 1155, (2011); and Greive et al., Biophys. J. 101, 1166, (2011)].

Public health relevance
Narrative for administrative supplement request for GM-15792-57 We request funds to enable the purchase of a replacement surface plasmon resonance (SPR) instrument that will support our ongoing studies of DNA structure and dynamics within functional protein-DNA complexes using fluorescent probe-substituted DNA constructs with advanced spectroscopic techniques. These complexes operate as ‘macromolecular machines’ within living cells to faithfully replicate (copy) the DNA genome into the daughter cells during cell division, to transcribe and process specific messenger RNA sequences to permit ‘expression’ of defined genes, and to direct the synthesis of specific required proteins at various stages of development. The requested supplementary funds will permit us to replace aging equipment that is central to a program of research that uses the methods of physics and chemistry to understand the molecular processes that are involved in the function and regulation of these macromolecular machines of genome expression, in part because understanding these central processes in molecular detail will help in the development of specific tools to control diseases of anomalous gene expression and development, including various forms of cancer and related genetic disorders.